Complexity, Cooperation and Community in Cancer

The proposed Center for Cancer Systems Biology, to be known as the Center for Complexity,
Cooperation and Community in Cancer, is a joint effort by the systems biology and cancer biology
communities at the University of California Irvine (UCI), as represented by two campus-wide research
organizations, the Center for Complex Biological Systems and the UCI Cancer Research Institute. The
center will tackle a variety of basic and fundamental questions about cancer systems, and why they are
organized as they are. The premise underlying the research program of the center is that cancer cells
proliferate and evolve in complex environments that have been highly selected for the robust control of
growth and differentiation, and that the behaviors of cancer cells can only be fully understood in the
context of the design principles that govern that control.
As described in this proposal, the center will carry out three coordinated, team-oriented research projects
on the role of context, cooperation and community in the initiation and progression of cancer. One
project will leverage new observations from xenograft models of colon cancer to investigate non-genetic
heterogeneity in solid tumors, both its origins and its relevance to tumor growth and response to therapy.
A second project will investigate the cellular origins of melanoma, seeking to clarify the relationship
between melanoma and the benign lesions (melanocytic nevi) that are driven by a common oncogenic
event. This work will focus on interactions among melanocyte precursors, within the skin environment,
and under conditions that promote progression from benign to malignant. The third project will focus on
improving models of chronic myeloid leukemia (CML) and its treatment, taking into account interactions
between hierarchical lineages, intercellular feedback, and dynamics. All three projects will combine
mathematical modeling, genomics, and experimental manipulation of animal models. All three will be
served by a core facility for investigating tumor cells at the single cell level, providing access to the latest
in single-cell genomic, transcriptomic and other technologies. The center will also support short-term,
interdisciplinary pilot projects initiated both by faculty and by trainees (graduate students and
postdoctoral fellows), as well as a wide variety of outreach activities aimed at expanding and enriching
the cancer systems biology community both within the university, in the larger scientific community, and
among the public. Finally, the center will coordinate its research and outreach activities with those of
other centers in the NCI Cancer Systems Biology network.

Public health relevance
The Center for Complexity, Cooperation and Community in Cancer will foster scientific research and outreach focused on advancing the hybrid field of cancer systems biology. Collaborative, interdisciplinary projects will use animal models, genome-wide analysis, and mathematical modeling to address fundamental questions about cancer and its origins. Projects focused on colorectal cancer, melanoma and leukemia will be complemented by pilot studies and diverse scientific outreach activities.